RESPONSE TO HEPATITIS B VACCINE IN CHILDREN WITH ASTHMA, STAGE 1

The purpose of this study is to determine if treatment of atopic asthmatic children with inhaled anti-inflammatory agents changes the specific immunoglobulin isotype and antigen specific peripheral blood CD4+ cell cytokine profile response to Hepatitis B (a neoantigen) and tetanus toxoid (a recall antigen).